CORE--TISSUE CULTURE

The objective for the Tissue Culture Core is to provide the Program Project investigators with a well-equipped, centralized facility in which to maintain cells in culture and to provide tissue culture services that are of uniform quality and more economical than would be possible through individual projects. Our positive results during this current funding period is supporting basic cell culture efforts is now being extended to facilitating other types of culture technologies essential to progress in the newly proposed studies.